HLA-D AND T CELL RECEPTOR GENES IN HUMAN DISEASE

This project, which is submitted for its second competitive renewal, has been directed toward an understanding of disease susceptibility as it relates to HLA and T cell receptor genes. Here we extend these studies to a comprehensive analysis of the critical T cell target antigens in the two disease models we have studied to date: insulin dependent diabetes mellitus (IDDM) and rheumatoid arthritis (RA). Additionally, we will extend susceptibility studies to the peptide transporter genes with a focus on TAP-1. Finally, we will attempt to isolate peptides from MHC molecules in both disease models.